Mechanisms of immune homeostasis and regulation of intraocular inflammation

Allogeneic hematopoietic cell transplantation (HCT) is inaccessible to many patients with hematologic malignancies for lack of HLA-matched donors. Although nearly all patients have HLA haploidentical donors, HLA-haploidentical HCT still results in high mortality due to prohibitive rates of severe GVHD. Increase of proinflammatory cytokines and reduced levels of regulatory lymphocytes drive GVHD development. We treated mice with GVHD with i35-Greg cells or i35-exosomes found that adoptive transfer of i35-Breg cells or i35-exosomes suppress GVHD. It is notable that i35-Bregs suppressed GVHD and more than 75% of mice that receive i35-Breg therapy survived more than 3 months after allogeneic transplantation.